Trans-Acting Factors Causing Cell-Specific Gene Control

Summary Dr. Ken Zaret (R01GM36477) and his NIGMS-funded collaborator Dr. Matt Good (R35- GM128748) request supplemental funding to purchase a Surface Plasmon Resonance device, to allow inter-molecular interactions to be quantified more accurately and faster than we can do by present means. The equipment would help advance our research substantially. This is a one-time request for equipment that costs $46,954, with $40,000 requested from NIGMS and the remainder from our Department (see Chair's letter).

Public health relevance
Project Narrative: The long term public health goal of the work is to use our mechanistic insights into the ways transcription factors overcome chromatin barriers in order to generate new cells that will be of medical interest. There are many examples of cell reprogramming and trans-differentiation in the literature, but creating new cells that exhibit terminal differentiation and can function in an animal remains a challenge. The next grant period will employ mechanistic studies of transcription factor interactions with artificial chromatin fragments in vitro and native chromatin in vivo, and use the information to improve the ability to control cell fate so that reprogrammed cells function properly in transplanted animals.